Expression and Function of the Guanylin Ligand Family

DESCRIPTION (provided by applicant): Guanylin and uroguanylin are peptides that are expressed in intestinal epithelia and were identified because of their ability to bind to the transmembrane receptor, guanylate cyclase C (GC-C). Ligand binding to GC-C, also expressed on intestinal epithelial cells (IEC), elevates intracellular cGMP levels which in turn elicits transmembrane ion movement via the cystic fibrosis transmembrane conductance regulator and the Na+/H+ Exchanger 3. This signaling pathway has direct clinical relevance in that the acute diarrheal illness caused by enterotoxigenic strains of E. coli is mediated by the heat stable toxin, a super-agonist of GC-C. However, receptor guanylate cyclases that are highly homologous to GC-C are important in regulating pro-inflammatory gene expression, barrier function, and inflammation in extraintestinal organs. While a significant amount of published work has centered on GC-C regulation of fluid secretion, almost nothing has been reported regarding the putative role for GC-C in intestinal inflammatory disease. Moreover, recent findings indicate that GC-C ligands are reduced in patients with Inflammatory Bowel Disease. Therefore, a better understanding of this receptor-ligand system will likely shed light not only on the pathophysiology of toxigenic diarrhea, but will also serve to close the current gap in our understanding of GC-C and its ligands in the pathogenesis of colitis. Consistent with this goal, our preliminary data indicates that signaling through GC-C has an important role in suppressing pro-inflammatory gene expression in intestinal mucosa, and is required for intestinal barrier function. Further, we demonstrate an intriguing differential sensitivity to innate immune cell-driven intestinal injury versus T cell-mediated colitis. Therefore, the overarching hypothesis of this application is that GC-C, via ligand-induced cGMP generation, is essential for mucosal immune homeostasis. We will address this in the following aims. Specific Aim 1 will investigate GC-C-mediated suppression of pro-inflammatory gene expression using in vitro biochemical analysis and existing, novel gene-targeted mice. Specific Aim 2 will evaluate the requirement for GC-C signaling in maintaining intestinal barrier function through the use of in vitro IEC monolayers and GC-C and ligand knockout animals. Specific Aim 3 will investigate the role of GC-C in susceptibility to intestinal inflammation using multiple in vivo models of colitis in GC-C null mice. The studies in this proposal will define the role of GC-C and its ligands in mucosal pro-inflammatory gene expression and barrier function, and will delineate the impact GC-C has on susceptibility to intestinal inflammation. Furthermore, these studies will lay the groundwork for translational research involving this receptor as a therapeutic target for the treatment of intestinal inflammatory disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: The number of individuals in the United States that suffer from Inflammatory Bowel Disease (IBD) is in excess of one million. The existing treatments for IBD are not effective at diminishing disease for many patients, making the development of additional therapeutic options an important goal. We have identified a novel connection between Guanylate Cyclase C (GC-C) activity and mucosal immunity This proposal will investigate the mechanism of GC-C suppression of experimental colitis as well as the utility of modulating GC-C signaling as a viable approach to treat IBD.